SYNTHESIS AND PROPERTIES OF ORGANOCOBALT COMPLEXES

Two important unanswered questions concerning B12-dependent enzymic processes are: How does the enzyme promote the homolytic cleavage of the Co-C bond of coenzyme B12? Does the Co play a role in the poorly understood rearrangement reactions such as the conversion of methylmalonyl-CoA to succinyl-CoA by methylmalonyl mutase? These questions have not been fully answered for several reasons. The B12-dependent enzymes are large, making X-ray and some spectroscopic studies difficult. The cofactor generally lies in a protected enzyme pocket inaccessible to probe reagents. Spectroscopic techniques such as CD, vis-UV and EPR which have usually been employed are either limited to paramagnetic species or do not readily yield structural information for such complex molecules. The only reported alkylcobaltcorrin X-ray structure is that of coenzyme B12. One consequence of this limited information is that there is not clear relationship between structure and spectra. Also, there is an inadequate background with which to evaluate the structural feasibility of putative intermediates or to assess the steric factors leading to Co-C bond cleavage. To address these questions, detailed studies of alkylcobaltcorrins and related models are proposed. The range of conformations possible for alkylcobalamins will be defined via the synthesis of sterically strained alkylcobaltcorrins (cobalamins, cobinamides and the heptamethyl ester of cohyrinic acid) and models compounds (such as Cosaloph and "Costa" model compounds). The effect of structural changes induced in these systems will be assessed by X-ray crystallography, spectroscopy (CD, NMR, Raman) and by reaction rates and mechanistic studies (Co-C bond cleavage, ligand exchange, model rearrangement reactions). Changes are anticipated in the Co-to-axial ligating atom bond lengths, the Co position relative to corrin, corrin side chains, etc. The structure of the prototype alkylcobalamin, methylB12, is nearing completion. Steric strain in the alkyl linkage between Co and adenine in cobalamin analogues will also be varied and the interaction of the analogues with B12-dependent enzymes such as ethanolamine ammonia lyase will be investigated. With the spectroscopic background developed, CD, vis, NMR, and Raman studies will be initiated on B12 holoenzymes.